Emergence of arm reaching behavior and lateralization of motor control in infancy

It is crucial to understand how infants learn to progress from spontaneous movements into goal-directed, refined
motor skills. Infant learning is the focus of early intervention programs, and the need for effective early
intervention is great. Until we understand the mechanisms of development and what promotes or inhibits
successful infant learning, we cannot design optimal early intervention. Our specific objective is to longitudinally
study infant experience (infant and environmental factors) and underlying neural substrates
(electroencephalography (EEG)) as infants learn arm reaching, an early, foundational motor skill.
Current theories suggest that infants learn through a repeated perception-action process and that experiencing
error is the key mechanism for successful infant learning. Thus, Aim 1 will measure error rate longitudinally
across the emergence and refinement of reaching. In Aim 1 we will determine the relationship between error rate
and the development of reaching skill. We hypothesize that infants will demonstrate a high error rate
(errors/attempts) near reaching onset that decreases as they refine the skill, supporting the idea that making
errors is a key experience in order for learning to occur. Aim 2 will focus on individual infant and environmental
factors that predict age of onset of reaching. In Aim 2 we will identify infant and environmental factors related to
the age of reaching onset. Infant factors are motor experience (amount and type (unilateral or bilateral) of daily
arm movement experience) and cognitive development status. Environmental factors are level of maternal
education, quality of caregiver-infant interactions, nutrition, and sleep. We hypothesize that these factors are
related to the age at which infants are observed to begin to reach, and we will determine the strength of the
associations and characteristics of infants reaching at different ages. The results will identify targets for
intervention that are most likely to be successful. Aim 3 will use EEG to determine how brain function changes
as reaching is refined from an unstable skill to a successful, lateralized (typically right arm preference) movement.
Using EEG will allow us to collect data in the home, both resting state and during arm movements. In Aim 3 we
will identify patterns of concurrent brain activity that differentiate between spontaneous arm movements, early
reaching attempts, and skilled reaches in infants with typical development. Based on our pilot data, we
hypothesize that frontal-parietal connectivity increases, interhemispheric connectivity decreases, and sources of
EEG activity shift from bilateral to unilateral as reaches become more goal directed, successful, and lateralized.
Aims 1–3 focus on infants with typical development; exploratory Aim 4 contrasts our findings with a population
likely to show impairment in learning to reach: infants at high risk for cerebral palsy. In exploratory Aim 4 we will
describe patterns of concurrent brain activity during spontaneous arm movements, early reaching attempts, and
skilled reaches in infants at high risk for cerebral palsy. Our results will determine the most relevant factors
related to an infant’s ability to refine his brain function and neuromotor control as he learns to reach.

Public health relevance
Project Narrative How infants learn to progress from spontaneous and seemingly disorganized movements into goal-directed and refined motor skills is unknown. Until we understand how to promote successful infant learning, we cannot design optimal early intervention for infants with or at risk of neuromotor developmental disabilities. The objectives of this project are to 1) determine the relationship between error rate and the development of reaching skill in infants with typical development, 2) identify individual and environmental factors related to the development of skilled reaching in infants with typical development, 3) identify patterns of concurrent brain activity that differentiate between spontaneous arm movements, early reaching attempts, and skilled reaches in infants with typical development, and 4) identify patterns of concurrent brain activity that differentiate between spontaneous arm movements, early reaching attempts, and skilled reaches in infants at high risk for cerebral palsy.